Vanderbilt University Biomolecular Multimodal Imaging Center for 3-Dimensional Mapping of the Human Kidney

PROJECT SUMMARY – Kidney OSP.
The overall structure and anatomical relationships among different cell types within the human kidney are well
understood, and experimental studies have defined the molecular and functional characteristics of individual
kidney cell types. However, remarkably little is known about the integration, interactions, and molecular cross-
talk between the different cellular compartments in normal kidneys. The goal of the Kidney OSP is to address
this limitation in current knowledge by developing a fully integrated, multimodal molecular imaging pipeline to
characterize the cellular and molecular organization of the human kidney. Building on our already established
HuBMAP characterization pipeline, we will bring together imaging mass spectrometry, highly multiplexed
immunofluorescence microscopy, autofluorescence microscopy, stained microscopy, spatial transcriptomics,
spatial proteomics, and single-cell RNA-seq. Each modality was specifically chosen to enable the construction
of a kidney molecular atlas that spans a wide range of spatial scales (e.g., single cells, functional tissue units,
neighborhoods, and whole organs) and molecular classes (e.g., metabolites, lipids, proteins, and RNAs). The
result will be a comprehensive molecular atlas of the human kidney that will be fully compatible with other
molecular interrogation pipelines and data generated by HuBMAP researchers. In Aim 1 we will continue our
kidney tissue collection and management protocols that build on our established kidney biobanks and tissue
acquisition programs to create a representative molecular atlas of the human kidney. Aim 2 establishes clinical
and histological standards and metrics that will be used to determine the suitability of samples that can be
entered into the analytical pipeline. The focus of Aim 3 puts forth a strategy for 2-D and 3-D multimodal imaging
and deep multi-omic analysis of the human kidney. Assay development on surgical resection specimens will be
applied to whole organs using non-transplantable donor kidneys to construct 3-D molecular atlases. Finally, Aim
4 will scale up the kidney-specific characterization pipeline to generate representative 3-D molecular atlases
from multiple, intact human kidneys.

Public health relevance
PROJECT NARRATIVE – Kidney OSP This application proposes the continuation of the Biomolecular Multimodal Imaging Center (BIOMIC) at Vanderbilt University, a Tissue Mapping Center associated with the Human BioMolecular Atlas Program (HuBMAP). The mission of BIOMIC is to build a platform of integrated technologies for imaging and molecular analysis that enables the construction of comprehensive 3-dimensional molecular atlases of human tissues. The Kidney OSP aims to 1) procure and manage human tissue specimens, 2) determine and mitigate non-biological pre-analytical factors, and 3) develop scalable multimodal imaging and deep multi-omic assays for the human kidney.